Impact of a multimodal intervention to reduce dual stigma and improve treatment outcomes in HIV/Drug-resistant TB co-infected patients in KwaZulu-Natal, South Africa

Project Summary/Abstract Tuberculosis (TB) remains the leading cause of morbidity and mortality worldwide among people living with HIV. Globally, the incidence of multidrug-resistant tuberculosis and extensively drug resistant tuberculosis, the most drug-resistant forms of TB, has approximately doubled over the past fifteen years. Nowhere has this increased incidence generated more concern than South Africa where interactions between TB and generalized HIV/AIDS epidemics are causing “explosive” TB incidence and case-fatality threatening to undermine the progress reached with antiretroviral therapy (ART). Stigma, a key predictor of outcomes in multi-and extensively drug-resistant TB (M/XDR-TB) and HIV treatment, is understudied in high burden TB/HIV settings. Patient losses during transitions in the TB/HIV care continuum are frequent and lead to increased mortality. Demands of M/XDR- TB HIV treatment are severe including extraordinary pill burden, severe adverse effects, lengthy treatment, and feelings of isolation, with few parallels in modern medicine The goal of the proposed study is to address issues of stigma and subsequently enhance adherence and retention in care for M/XDR-TB HIV patients in South Africa through a community-based strategy, including use of community adherence groups, with the overarching goal of promoting patient engagement in a continuum of M/XDR-TB HIV care. Although well established for ART, this is the first application of this community-focused intervention to M/XDR-TB HIV co-infected. To achieve this goal, we will characterize critical implementation gaps in our understanding of stigma in drug-resistant TB and HIV, use this data to inform an evidence and theory-based intervention to improve adherence and promote retention in care, and rigorously evaluate the intervention with a mixed methods approach using quantitative clinical outcomes and qualitative understanding of impact on barriers and facilitators At the conclusion of these studies we will have addressed critical gaps in our understanding of stigma in people living with drug-resistant TB and HIV, evaluated the potentially predictive value of novel stigma abating measures and assessed the impact of an exploratory, culturally acceptable, and patient-oriented intervention to remove stigma.

Public health relevance
Project Narrative The growing incidence and associated complications of multi and extensively drug-resistant and (MXDR) TB results in major losses in the continuum of care among HIV co-infected individuals in South Africa, and threatens national HIV as well as TB control efforts. Non-adherence to treatment is a major cause of poor treatment outcomes in people with MXDR-TB and HIV, and our early research in South Africa suggests that stigma and related social factors may play a crucial role in shaping adherence behaviors. This study will use a mixed-methods approach to elucidate the mechanisms by which stigma may compromise medication adherence to MDR-TB and HIV treatment, and a randomized control trial to evaluate a comprehensive adherence intervention on stigmas and clinical and biological outcomes among MXDR-TB HIV co-infected patients in South Africa.